Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The overall goal of the Administrative Core (Admin Core) is to provide the organizational infrastructure necessary
to stimulate research and to expedite the translation of discoveries into new and better treatments for
glioblastoma (GBM). The Admin Core will facilitate these activities by providing leadership, financial
management, and an administrative structure designed to efficiently coordinate the activities of the research
projects, shared resources cores, the Glioblastoma Therapeutics Network (GTN), and the Network Coordination
Center (NCC). In addition, the Admin Core incorporates a biostatistical component and will oversee all statistical
support to all Projects and Cores. Specifically, the Admin Core will: 1) Provide leadership, organizational support,
oversight of data management, and financial management for the U19 investigators; 2) Promote integration of
the three projects to enhance interaction among the three participating institutions (City of Hope, University of
Alabama at Birmingham and the Translational Genomics Research Institute), the internal advisory board (IAB)
and other GTN U19 Research Centers; 3) Facilitate collaboration with other U19 Research Centers to fund and
oversee pilot projects; 4) Serve as the liaison working with the NCC to implement network best practices and
policies; and 5) Provide biostatistical expertise to support basic science, translational, and clinical research.
The proposed U19 structure, consisting of three participating institutions, will be directed by Drs. Portnow
(Contact PI) and Badie (MPI) at City of Hope. The members of this team are well acquainted and have a track
record of collaborating on GBM research projects and leading the City of Hope Brain Tumor Program. Through
performance of the Specific Aims, the Admin Core will ensure effective functioning of the U19 to maximize our
efficiency, conserve resources, and expedite clinical development of novel therapies for GBM.